Signaling Pathways That Differentiate Dendrite and Axon Development

DESCRIPTION (provided by applicant): Information processing in the nervous system relies on the separation of dendrites and axons. However, little is known about how dendrites and axons develop into distinct compartments. The long-term goal of this application is to define how neuronal compartmentalization is achieved during the development of neural circuits and how defects in that process lead to neurological and psychiatric diseases. The objective of this application is to delineate the signaling pathways that separate dendrite and axon development. Recent genetic studies on Drosophila have demonstrated that the fibroblast growth factor (FGF) receptors differentially control dendrite and axon development. The central hypothesis of this application is that the FGF receptors activate distinct signaling pathways to differentially control dendrite and axon development. We will test this hypothesis by pursuing three specific aims: 1) ) Identify the signaling pathway through which FGF receptors control dendrite-specific development;2) Determine whether FGF receptors regulate axon development through pathways different from dendrite development;3) Determine whether the roles of FGF receptors in the differential development of dendrites and axons are conserved in mammalian neurons. The approach is innovative because it takes advantage of genetic analysis to investigate the developmental differences between dendrites and axons in vivo and combines both Drosophila and mammalian systems to study evolutionarily conserved mechanisms. The proposed research is significant because it is expected to advance knowledge of the signaling mechanisms underlying the differential development of dendrites and axons. That knowledge is needed to develop strategies that will allow preferential or specific manipulations of dendrite or axon development in disease conditions and in animal models to interrogate the functions of the nervous system. PUBLIC HEALTH RELEVANCE: How the information-receiving (dendrites) and -sending (axons) parts of neurons form is poorly understood. This knowledge is important because many neurological and psychiatric diseases involve defects in these two parts of neurons. The proposed research will provide the knowledge needed to develop therapeutic strategies having subcellular precision to correct defective dendrites and axons in human diseases.

Public health relevance
How the information-receiving (dendrites) and ¿sending (axons) parts of neurons form is poorly understood. This knowledge is important because many neurological and psychiatric diseases involve defects in these two parts of neurons. The proposed research will provide the knowledge needed to develop therapeutic strategies having subcellular precision to correct defective dendrites and axons in human diseases.